Digital phenotypes from a low-cost smartwatch to inform early detection of Alzheimer's disease and related dementias

PROJECT SUMMARY/ABSTRACT
Currently, more than 6 million Americans are suffering from clinical Alzheimer's disease and Alzheimer's
related dementias (AD/ADRD). By 2050, this number is projected to rise to 13 million. Due to this expected
increase, there is a great need for sensitive, easily implemented, objective, and scalable methods to identify
cognitive change and differentiate individuals along the AD continuum. Neuropsychological assessments are
useful for characterizing dementia symptoms, clinical diagnosis, and monitoring, but they involve burdensome
procedures and lack ecological validity. Neuroimaging and blood markers of proteins associated with risk of
clinical AD/ADRD are often inaccessible, expensive and/or invasive, and their link to patient behavior is
inconsistent. To address these drawbacks, digital phenotyping is a novel approach that allows for passive and
continuous monitoring of behaviors and physiological metrics in everyday life using technology such as a
smartphone or smartwatch. In this study, the construct validity of smartwatch-derived metrics will be
investigated against conventional neuropsychological measures and questionnaires across preclinical
AD/ADRD stages. A diverse sample of 90 participants aged 55 and older with either healthy cognition or mild
cognitive impairment will be recruited from the Philadelphia region. Participants will be given a Garmin
Vivosmart 4 smartwatch and will wear it 23 hours/day to passively monitor sleep, heart rate variability, and
physical activity data, which then will be deidentified and transferred to a secure server daily for 30 days. A
daily survey will be completed through study software that is downloaded on participants' smartphones to
contextualize passive data collection metrics. At the first study visit, participants will complete conventional
neuropsychological tests and self-report measures of everyday function. The primary aim will examine the
validity of a smartwatch-derived digital phenotyping protocol against conventional clinical measures.
Exploratory aims will investigate 1) associations between smartwatch metrics and demographic and contextual
factors and 2) meaningful groupings of participants with unique patterns of smartwatch metrics (i.e.,
phenotypes) and their relations to clinical status and conventional cognitive measures. The proposed training
plan was developed with input from a team of interdisciplinary experts in everyday cognition in aging, digital
ethics, longitudinal statistical methods, and engineers studying physiology with the goal of developing a high
level of competence in statistical methods for wearable devices, understanding physiological measurement,
knowledge on ethics and privacy in the wearable space, and the application of digital phenotyping in a diverse
aging population.

Public health relevance
PROJECT NARRATIVE As the aging US population increases and interventions for dementia become available for early stages, there is a growing need for low-cost sensitive tools to detect early cognitive decline in large samples. Digital phenotyping, a novel approach involving passive data collection from sensors on personal devices, such as smartwatches, could fill this gap to estimate early autonomic dysfunction and health behaviors associated with early cognitive decline. This project will examine the validity of several metrics from a commercially available and low-cost smartwatch in a diverse sample of older adults, which could have broad implications for health behavior monitoring, early detection of cognitive decline, and targeted interventions.